Pre and Post-Doctoral Training in Joint Health

We propose a predoctoral and postdoctoral training program in the multi-disciplinary area of musculoskeletal
biology and mechanics with the ultimate aim of developing future leaders in orthopedic- and rheumatology-
related research. The program emphasizes research training in joint health, encompassing five major
programmatic areas: osteoarthritis and cartilage, total joint replacement, bone disease and regeneration, spine
degeneration, and small molecule therapeutics. Dr. Rick Sumner (Anatomy & Cell Biology) will serve as the
principal investigator with Dr. Markus Wimmer (Orthopedic Surgery) and Dr. Rachel Miller (Internal Medicine-
Rheumatology) as the co-directors. We are requesting support for two predoctoral, three postdoctoral fellows
and three short-term trainees. Joint health is a theme that connects many departments at Rush, offering an
environment and intellectual capital available to trainees that is unique in the nation. The multidisciplinary
training that is offered integrates the research endeavors of scientists in basic science and clinical departments
with clinician investigators, caregivers, and educators who specialize in musculoskeletal disease and joint
health. The training themes for this grant represent the strengths of the preceptors who have been selected as
mentors. Training will take place in the laboratories of 28 faculty in 3 basic science departments (Anatomy &
Cell Biology, Microbial Pathogens & Immunity and Physiology & Biophysics), 3 clinical departments (Internal
Medicine, Orthopaedic Surgery and Pediatrics) and one center (Rush Alzheimer’s Disease Center). There are
currently 15 predoctoral students and 27 postdoctoral fellows in the training grant faculty labs. The 28 faculty
are principal investigators on grants totaling nearly $20M in annual direct costs, mainly from NIH grants. We
will continue to make every effort to recruit candidates with clinical training into our program. One means to
encourage interest among clinical trainees is to provide meaningful introductory research experiences,
justifying the continuance of our request for short-term trainee positions, which so far have been exclusively
used by medical students in our program. There is a deep history of collaborative research among
musculoskeletal researchers at Rush. We will take advantage of a reorganized Graduate College, a very
strong mentoring program and an active postdoctoral research society that has created a vibrant community
for trainees. Trainees will focus on knowledge acquisition, skill development, communications, professionalism,
leadership and management skills, and responsible conduct of research. Each mentee, his/her primary advisor
and thesis or mentoring committee will use individual development plans to guide their efforts with a focus on
publishing and participating in national research meetings and submitting independent grants (F31’s for the
predocs and F32’s for the postdocs). We anticipate that trainees will be assigned to the T32 for two years with
the expectation that support will transfer to individual awards or their preceptors’ grants. After completing our
program, we expect the trainees to continue their career path as independent, team-oriented, investigators.

Public health relevance
Musculoskeletal diseases affect about one-third of the U.S. population. The estimated total cost of this disease burden in the U.S. is approximately 5.2% of the country’s gross domestic product. We propose to improve the research infrastructure by training predoctoral students and postdoctoral fellows with the long-term goal of decreasing this societal burden through creation of a workforce that is adept at acquisition and application of new knowledge.